Pelvic Floor Disorders Network Data Coordinating Center: Administrative Supplement: Noncontinuing Sites

Contact PD/PI: GANTZ, Marie
PROJECT SUMMARY/ABSTRACT
RTI International serves as the data coordinating center (DCC) for the NICHD Pelvic Floor
Disorders Network (PFDN) in support of its mission to improve the care of women with pelvic
floor disorders (PFDs) by conducting well-designed multicenter observational studies and
clinical trials to inform diagnosis, prevention, and treatment. RTI is providing the Network with
statistical leadership in study design and data analysis and operational support through data
management and logistical services. Specifically, the DCC (1) leads innovative study designs
and analyses to address challenges specific to PFD research, including bench-to-bedside
translational studies, by providing expertise in biostatistics, statistical genetics, psychometrics,
health economics, machine learning, and other fields and collaborating with clinical investigators
to develop rigorously designed studies with outcome measures important to women with PFDs;
(2) provides tools for communication and collaboration to facilitate rapid development of
protocols and web-based systems for electronic data capture (including direct capture of
patient-reported outcomes via mobile applications), biospecimen tracking, omics data pipelines,
and training; (3) conducts data management, quality assurance, and monitoring procedures
throughout the life of each study, capitalizing on centralized and remote monitoring capabilities
for efficient use of network resources; (4) reports on data quality, protocol adherence, and
safety, and perform statistical analysis for presentation at national and international
conferences, and publication in top-tiered journals; and (5) coordinates remote and in-person
meetings, manage subcontracts, provide automatic capitation payments to sites, and manage
biospecimen transport and storage, study drug acquisition, and equipment and supplies
distribution as needed to support network studies.
Project Summary/Abstract

Public health relevance
Contact PD/PI: GANTZ, Marie PROJECT NARRATIVE The PFDN was established in 2001 to improve the care of women with PFDs by conducting well-designed multicenter studies to inform diagnosis, prevention, and treatment. A qualified, experienced DCC is critical in helping the PFDN optimize research productivity through effective study design, implementation, data collection, quality assurance, monitoring, and statistical analysis. RTI will continue to provide multidisciplinary expertise to support high-impact collaborative clinical research studies and provide communications and logistical support to optimize the efficiency and productivity of the Network. Project Narrative